MolQTL: A comprehensive resource for molecular quantitative trait loci inhuman cancer.

Abstract
important
noncoding
functional
data Our group
constructed a series of data portals for molQTLs, including data portals for expression QTLs (eQTLs),
methylation QTLs (meQTLs), and splicing QTLs (sQTLs) based on a large number of cancer samples from
TCGA. We demonstrated that these QTLs are associated with patient survival, and/or overlap with GWAS
linkage disequilibrium regions. These related data resources have been broadly accessed since their releases,
nucleotide polymorphisms (SNPs), the most common type of human genetic variants, play
roles in shaping complex human traits and causing diseases. Most risk-related SNPs are located in
regions and it remains a challenge to understand the effects and molecular mechanisms of
SNPs . ) analysis is a statistical method to link genotyping
and molecular phenotype data to interpret the effects of genetic variants in complex traits.
Single
,
Molecular quantitative trait loci (MolQTL
and highlighted
discovery
the opportunities t o understand the functional significance of genetic variants and to utilize the
of molQTLs in precision medicine.
The goal of this proposal is to enhance, expand, and promote our existing data resources that will
bridge the genetic variants and different molecular features through molQTL analysis, providing a unique data
resource for understanding the functional effects of genetic variants and facilitating access to and
understanding of complex datasets for non-expert users. In Aim 1, we will enhance our existing data resources
with additional analytical modules. We will identify molQTLs with highly efficient and accurate approaches (Aim
1.1). We will fine-map causal variants and causal effects through mediation analysis (Aim 1.2). We will
evaluate anti-cancer drug response from molQTLs (Aim 1.3). We will determine the associations between
genetic variants and immune features through molQTL analysis (Aim 1.4). In Aim 2, We will expand and
promote our existing data resources. We will identifyRNA editing QTLs (edQTLs, Aim 2.1), 3'-UTR alternative
polyadenylationQTLs (apaQTLs, Aim 2.2), andprotein QTLs (pQTLs, Aim 2.3). We will develop a unified data
portal to integrate all the molQTL types described in this proposal (Aim 2.4). We will promote MolQTL and
active interaction with the user community through providing written documents, video tutorial and hands-on
workshops (Aim 2.5). We expect that our molQTL data portal will serve as a comprehensive, unique, and user-
friendly data portal to identify and interpret the functional consequences of genetic variants.

Public health relevance
Project Narrative Single important nucleotide polymorphisms (SNPs), the most common type of human genetic variants, play roles in shaping complex human traits and causing diseases, andadvancements in high-throughput technologies have enabled researchers to generate multiple types of omics data used in the identification and analyses of these SNPs. Our group constructed a series of data portals for molQTLs, including data portals for expression QTLs (eQTLs), methylation QTLs (meQTLs), and splicing QTLs (sQTLs) based on a large number of patient samples, and these related data resources have been broadly accessed since their releases. The goal of this proposal is to enhance, expand, and promote our existing data resources that will bridge the genetic variants and different molecular features through molQTL analysis, providing a unique data resource for understanding the functional effects of genetic variants and facilitating access to and understanding of complex datasets for non-expert users.